Spatiotemporal Staging of the HIV-1 Preintegration complex

ABSTRACT
Approximately 1.2 million people in the US and ~40 million people worldwide are infected with HIV. In
spite of significant progress in HIV/AIDS research, anti-retroviral therapy (ART) remains the only treatment
option available for HIV-1 infection. ART has been highly effective in controlling the virus and making HIV
infection a manageable disease. Specifically, inhibitors of HIV-1 Integrase (IN) are used as the preferred drugs
in the current ART regimens. However, these inhibitors continue to face drug resistance and there is growing
concern of the adverse metabolic and neuropsychiatric effects of these inhibitors. Thus, there is a need for the
development of new and improved IN inhibitors for effective and long-term control HIV-1 infection. Such effort
is critically dependent on a better understanding of the mechanisms of HIV-1 integration. It is important to note
that studies of the preintegration complex (PIC) extracted from acutely infected cells have been instrumental in
defining the mechanisms of HIV-1 integration. Furthermore, PIC studies have played a central role in the
development of currently used IN inhibitors. Therefore, our proposal to define the mechanism of HIV-1 PIC
formation will generate new knowledge to promote the development of new and improved IN-based therapies.
Retroviral replication is dependent on the essential steps of reverse transcription (RTN) and integration.
In the case of HIV, the RNA genome is reverse transcribed into a DNA copy by the reverse transcription
complex (RTC). Then, the RTC transitions into a PIC by an unknown mechanism and undefined time. The PIC,
containing the viral DNA, the IN enzyme, and other viral/host factors, carries out integration. The prevailing
view is that HIV-1 RTN is completed in the cytoplasm and/or at the nuclear pore complex (NPC). Thus, nuclear
entry of the PIC is necessary to carry out HIV-1 DNA integration into the host chromosomes. However, new
evidence suggest that the intact HIV-1 capsid enters the nucleus and RTN is completed after the nuclear entry
step. A nuclear completion of RTN creates key knowledge gaps in our current understanding of the PIC. We
hypothesize that functional HIV-1 PICs are formed prior to the completion of RTN and nuclear entry protects
the integrity of the PIC-viral DNA. This proposal will test this hypothesis through three specific aims: Aim 1 will
define the link between the timing of functional PIC formation relative to RTN completion, Aim 2 will assess the
role of nuclear entry on PIC function, and Aim 3 will determine the spatiotemporal transition of the RTC to a
PIC. For these aims, we have developed a novel approach of quantifying PIC-specific integration activity and
measuring HIV-1 core-mediated DNA integration, coupled with the blockade of viral nuclear entry and time of
inhibitor addition assays. Together, these studies will define the mechanistic and kinetic link between HIV-1
RTN and PIC function. Most importantly, our team is uniquely qualified to successfully complete this timely
R01-project, since we have the expertise, reagents, and the tools required to study PIC biochemistry (Dash),
Capsid biology (Aiken), Nuclear entry (Campbell), and Integration (Engelman and Craigie).

Public health relevance
PROJECT NARRATIVE Reverse transcription and integration are two essential steps in retroviral replication. In this project, we will study the spatiotemporal staging of the HIV-1 preintegration complex and dissect a mechanistic link to the reverse transcription process. These studies will generate new knowledge on the mechanisms of HIV-1 integration and will promote the development of new and improved HIV-1 integrase-targeting inhibitors.